SGLT2 Inhibitors, Ketogenesis, and Ketoacidosis

PROJECT SUMMARY/ABSTRACT
Sodium-glucose cotransport inhibitors (SGLT2i) lower the plasma glucose concentration by promoting
glucosuria and have been shown to be effective in preventing cardiovascular events, including heart failure,
and in slowing the progression of chronic kidney disease in diabetic and nondiabetic individuals. However, the
uptake of the SGLT2i, especially in the general medical community but also by cardiologists and nephrologists,
has been retarded by the development of diabetic ketoacidosis. Although uncommon in T2DM, DKA occurs in
3-5% of T1DM individuals treated with SGLT2i and primarily for this reason the SGLT2i have not been
approved by FDA for use in T1DM individuals. Consequently, T1DM subjects have been excluded from all
large-scale CV and renal outcome studies. Further, the glucose lowering efficacy of the SGLT2i is blunted by
their stimulation of hepatic glucose production (HGP), which offsets by ~50% the amount of glucose excreted
in the urine. Therefore, a clearer understanding of the mechanisms involved in the stimulation of ketosis and
EGP are needed.
In the present grant proposal, we will employ innovative study designs with radioisotopes and stable isotopes
to elucidate the mechanisms via which empagliflozin augments hepatic glucose production and stimulates
ketogenesis (Protocols I, II, and III), while in Protocols IV and V we will examine whether pioglitazone can
block the SGLT2i-induced stimulation of ketosis and HGP. If this can be demonstrated, this would allow T1DM,
as well as T2DM, subjects to be safely treated with SGLT2i and to receive the cardiovascular and renal
benefits of this antidiabetic class of drugs.

Public health relevance
PROJECT NARRATIVE SGLT2 inhibitors are approved for the treatment of type 2, but not type 1, diabetes patients primarily because of the (i) increased incidence of diabetic ketoacidosis (DKA) in the later group, and (ii) stimulation of endogenous (hepatic) glucose production, thus impairing their glucose lowering effectiveness. A clearer understanding of the pathophysiologic mechanisms responsible for the stimulation of ketogenesis and hepatic glucose production, as well as treatment regimens that can effectively block the SGLT2i-induced stimulation of these two metabolic processes, are needed. In the present grant we will employ innovative study designs in combination with isotopes: (i) to elucidate the mechanisms via which SGLT2 inhibitors stimulate ketone production and hepatic glucose production (HGP), and (ii) to examine whether coadministration of pioglitazone, an antidiabetic agent approved by the FDA, with empagliflozin can prevent the SGLT2i-induced stimulation of ketosis and HGP.